American Society of Biomechanics Annual Meeting 2024

PROJECT SUMMARY/ABSTRACT
The American Society of Biomechanics (ASB) is the foremost society for biomechanics research and
engagement in the United States. The Society’s annual meeting brings together an interdisciplinary group of
researchers interested in the application of mechanical principles to biological problems, both basic and applied.
The research portfolio of ASB’s membership is highly interdisciplinary and complements the missions of the
National Institute of Child Health and Human Development (NICHD) Center for Medical Rehabilitation Research
(NCMRR) and National Institute on Aging (NIA) by fostering discovery and dissemination of scientific knowledge
through basic, translational, and clinical research that aims to enhance the health, productivity, independence,
and quality of life of people with physical disabilities, musculoskeletal diseases, and injuries, across the lifespan.
The 2024 annual meeting of the ASB, which will be held in Madison, Wisconsin, is being hosted by faculty at the
University of Wisconsin-Madison. The meeting will feature a variety of activities designed to foster a lively
interchange of ideas, including podium presentations, thematic poster sessions, invited symposia, keynote
lectures, poster presentations, topical tutorials, laboratory tours and a variety of mentoring and diversity events.
Student participation and mentoring are priorities for the Society. Meeting attendance is anticipated to exceed
800 delegates, of which nearly half are expected to be students. Mechanisms have been established to
specifically encourage and support the participation of women, persons from underrepresented backgrounds,
and persons with disabilities.
Under the proposed award, the Society will continue to administer its successful Diversity Travel Award program,
add a Faculty Scholars Award program to add breadth in new institutions and geographical areas, and organize
four key events: (i.) a Mentorship Lunch focusing on guidance and professional development strategies for early-
career scientists; (ii.) a Women in Science event convening the women in the Society to offer strategies for
development across all career stages; (iii.) a Diversity and Inclusion Lunch bringing together members of the
Society to network across boundaries and discuss strategies to support those who face uphill battles to full
inclusion; and (iv.) a STEM Educational Outreach Program engaging underserved youth and persons with
disabilities in the local community through a biomechanics activities exposition.
This grant application seeks funding to continue supporting Diversity Travel Awards for ~16 attendees of the
meeting, five Faculty Scholar Awards, and facilities and transportation costs for the STEM Educational Outreach
Program. NIH-R13-supported programs were offered at the last six (2015-2023) in-person annual conferences,
including travel awards to a diverse group of individuals with disabilities, from underrepresented backgrounds,
or facing economic barriers to attendance. These awards have proven to be successful in increasing diversity
amongst young active members who over time will become the future leaders of the Society and the field.

Public health relevance
PROJECT NARRATIVE The 48th annual meeting of the American Society of Biomechanics (ASB) will be hosted by faculty of the University of Wisconsin-Madison at the Monona Terrace Community and Convention Center in Madison, Wisconsin, from August 5-8, 2024. This proposal seeks funding to continue the Diversity Travel Award program and augment it with a Faculty Scholars Program and STEM Educational Outreach Program, targeted to increase the attendance of students, trainees, and junior faculty from underrepresented groups, with a focus on engaging women, minorities, and persons with disabilities. This program will provide opportunities for networking and the exchange of ideas around research themes intended to enhance the health, productivity, independence, and quality of life of people with physical disabilities and musculoskeletal diseases, addressing the missions of NICHD-NCMRR and NIA.